Characterizing determinants of primary KSHV infection among children and adolescents in Uganda

PROJECT SUMMARY / ABSTRACT
Kaposi sarcoma-associated herpesvirus (KSHV) remains an important cause of human disease worldwide.
While KSHV was first discovered nearly 25 years ago, many basic questions remain unanswered regarding the
timing of acquisition, route of transmission, risk factors for infection, as well as the virologic and immunologic
drivers of transmission. Addressing these questions is essential to the rational design of strategies to prevent
and treat KSHV-related disease.
Our group at the Fred Hutchinson Cancer Research Center (FHCRC) and the Uganda Cancer Institute (UCI)
has conducted comprehensive studies of primary human herpesvirus infections among children in Uganda as
part of our “PHICS” cohort study. By intensively following households of mothers and young children in Uganda
for one year, we were able to identify incident infections for multiple herpesviruses and to characterize kinetics
of oral shedding during primary and chronic infection for each virus. Importantly, we did not observe any incident
KSHV infection among infants, suggesting that the dynamics of KSHV transmission are unique, may be less
efficient than other human herpesviruses, and are likely to occur at an older age.
We now propose to extend the PHICS study approaches to comprehensively study KSHV. By precisely
defining the timing of primary infection, we aim to address several hypotheses related to the biology of the initial
steps of KSHV infection. To complete these studies, we will enroll a cohort of 80 KSHV-infected mothers and
their children in Kampala, Uganda. We will perform weekly home visits to document risk behaviors and to obtain
weekly oral swabs and monthly blood samples over a period of 18 months. Samples will be tested for KSHV
DNA by polymerase chain reaction (PCR) to identify incident KSHV infection in susceptible children and
adolescents as well as to characterize KSHV shedding in potential household exposures. Our specific aims are:
1) To determine the incidence and to define the viral, immunologic, and clinical features of primary KSHV
infection.
2) To identify the biologic and behavioral risk factors associated with primary KSHV infection.
3) To develop mathematical models that characterize KSHV shedding dynamics and virologic drivers required
for transmission.

Public health relevance
PROJECT NARRATIVE Kaposi sarcoma-associated herpesvirus (KSHV) is a virus that causes cancer, particularly in immunosuppressed individuals. KSHV is a common infection in some regions of the world, including sub-Saharan Africa, but many basic questions about how the virus is transmitted and what factors increase the risk for infection are unknown. This study will comprehensively characterize primary KSHV infection in a cohort of children and adolescents in Uganda to describe the biology of the initial steps of infection and to identify risk factors associated with transmission that could ultimately inform KSHV prevention strategies.